Extracellular matrix proteoglycans regulate toll-like receptors 4 and 9

Pseudomonas (P.) aeruginosa bacterial infections cause sight-threatening inflammation of the cornea. With
antibiotic resistance on the rise, additional treatment strategies are needed. To address this gap, the current
proposal focuses on novel interactions of pathogen recognition toll-like receptors (TLRs) with lumican (Lum),
an extracellular matrix protein of the cornea. The TLR-4 and TLR-9 receptors recognize P. aeruginosa cell
wall-derived lipopolysaccharides (LPS) and nuclear DNA, respectively, to induce pro-inflammatory cytokines
and type I interferons. LPS recognition by TLR4 at the cell surface of macrophages and dendritic cells (DCs)
leads to MyD88-dependent pro-inflammatory cytokine production, while endosomal TLR4 stimulates an
alternative pathway that additionally produces type I interferons. Endolysosomal TLR9, on the other hand,
stimulated by bacterial DNA or the synthetic TLR9 ligand CpGDNA, leads to the production of both pro-
inflammatory cytokines and type I interferons. Interestingly, Lum has opposing effects on TLR4 and TLR9; it
promotes TLR4 but suppresses TLR9 responses. We demonstrated that a tyrosine at the N-terminal end (Y20)
of Lum binds with the TLR-adaptor CD14 to promote cell surface TLR4 signals. Our preliminary data suggest a
potential caveolin-1 binding site at the C-terminal end (F228) of Lum that may be involved in caveolar
trafficking of TLRs. Our central hypothesis is that through binding CD14 and CAV1 Lum regulates
TLR4 and TLR9 locations within cells to promote TLR4 but restrict TLR9 signals, and this will
impact pro-inflammatory cytokine and type I interferon inductions to modulate inflammation
and regain of tissue homeostasis in keratitis. In the following aims we will test our hypothesis using
wild type mice, Lum-null mice, and macrophages and dendritic cells from these mice.
Aim 1) determine if Lum regulates TLR4 location and degradation, with CD14-binding preferentially
promoting the cell surface while CAV1 the endosomal TLR4 pathway, Aim 2) test if Lum increases the inactive
TLR9 pool in the cell surface and endosomal compartments to suppress its signals, and Aim 3) determine the
course of sterile keratitis mediated by LPS or CpGDNA and P. aeruginosa mediated infectious keratitis in Lum-
deficient and wild type mice and the effects of subconjunctival injections of mutated recombinant Lum with
loss of CD14 or Cav1 binding activity. Type I interferons have broad antibacterial and tissue protective roles in
addition to their well-known antiviral properties. Thus, a provocative translational potential is that by
manipulating the CD14 and the CAV1 binding properties of Lum, it will be possible to regulate the pro-
inflammatory cytokine and type I interferon induction pathways separately to resolve inflammation and
expedite corneal healing keratitis. Our study will develop a strong knowledge base on the role played by the
ECM in infection and inflammation for developing novel molecular therapeutic interventions in the future.

Public health relevance
Pseudomonas infection of the cornea is a common cause for sight-threatening inflammation of the eye. With antibiotic resistance on the rise additional treatment options are needed. We identified novel interactions between corneal extracellular matrix proteins and host pathogen recognition receptors that we propose to investigate for future development of treatment strategies for inflammation and corneal tissues damage.